Developing Transgenic Sindbis Virus as a Tool to Trace Neural Circuitry

DESCRIPTION (provided by applicant): Reconstructing the anatomy of the nervous system by defining the pattern of synaptic connections between identified neurons represents a crucial step toward developing a deep understanding of neural computation. Tools based on genetically modified viruses have demonstrated utility in this regard in the mouse, but the mechanisms by which these viruses cross synapses are unknown. More broadly, our understanding of how viral infections spread within the brain to cause encephalitis is limited, and there are presently few therapeutic options available to treat such infections. This proposal uses a new method to target production of virus particles to specific neurons, and uses genetic approaches to both understand the regulatory mechanisms that control virus spread, and to rationally design a new circuit tracing tool. Genetically engineered derivatives of Rabies virus and Pseudo-rabies virus that exploit the intrinsic ability of these viruses to spread through the brain have provided valuable tools for dissecting neural circuitry. However, the mechanisms by which these viruses cross synaptic connections is unknown, and these experiments require the physical injection of infectious virus particles, creating experimental variability and reducing throughput. Moreover, these tools have not been shown to work in the fruit fly, an important model system for unraveling microcircuit function. We therefore propose a different approach, one based on another virus, Sindbis, in which virus particles are genetically programmed to assemble specifically in subsets of neurons. Using this approach, we propose to use genetic approaches to first define the cellular mechanisms that regulate spread of virus infections in the brain. Then, using genetic engineering of the surface proteins of the virus, we will specifically target viral release to synapses. Finally, by combining manipulations of the host defense repertoire with our genetically modified virus genomes, we will perform proof of principle experiments that reconstruct specific neural circuits. Arboviruses, viruses that infect both insect and mammalian hosts, represent some of the most common causes of viral encephalitis in the United States. No targeted therapeutic agents, or vaccines, presently exist for the treatment of these infections, and poor clinical outcomes are frequent. Many of these viral agents are closely related to Sindbis, and understanding the cellular defense mechanisms that regulate its spread in the brain will inform our understanding of these pathogens. By identifying host proteins that the virus depends on for its replication and assembly, our studies will identify new therapeutic targets. In addition, the development of a new tool for defining the wiring diagram of neural circuits will enable further studies of brain function and dysfunction.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative Developing transgenic Sindbis virus as a tool for tracing neural circuitry PI: Thomas R. Clandinin Viral tools have proven invaluable for conducting anatomical reconstruction of neuronal connections in a variety of experimental contexts. However, the existing tools of this type have important technical limitations. At the same time, viral infection of the brain leading to encephalitis can cause severe clinical conditions for which our limited mechanistic understanding precludes the development of effective therapies. This proposal seeks to develop a rationally designed viral circuit-tracing tool, one that exploits genetic approaches to understand the viral and cellular mechanisms that regulate viral spread in the brain. __SpecificAimsTextDelimiter__ Specific Aims Encephalitic viral infections are difficult to treat, and are associated with a high mortality rate. Correspondingly, our understanding of the molecular mechanisms that regulate virus spread in the brain is limited. Infectious virus particles rely on cellular functions to infect and to replicate, and thus are often selective for specific cell types, including neurons. This selectivity has enabled molecularly engineered viruses to be used as tools to manipulate gene expression in cells of interest, and as a means of tracing neuronal connections in the brain through the trans-synaptic transfer of virus particles. In these applications, purified particles are injected into a tissue of interest, reducing the throughput and reproducibility of viral infection through the required physical manipulations of the tissue and virus. A possible solution to this problem, the self-assembly of viral particles from transgenes ("launching") has previously only been successful in cultured cells, or yeast. We have achieved launching of infectious particles of Sindbis virus in Drosophila neurons, in vivo. This capacity affords us the opportunity to examine both viral replication and host defense in the context of specific cell types, focusing specifically on the brain. Moreover, these efforts provide a platform for the development of a viral tool for tracing neuronal circuits in this animal, a capacity that is critical to the further use of this model system for unraveling neural computation. We propose to use transgenic Sindbis genomes in Drosophila to develop a sufficient understanding of viral replication and host defense so as to allow genetically targeted launching of virus particles in neurons to trace brain circuitry. In the first Aim, we hypothesize that by taking advantage of Drosophila genetics, combined with our launching paradigm, we will be able to define both general and cell-type specific host defense mechanisms, as well as viral dependencies on host factors. In the second aim, we propose to develop this system into a reliable molecular-genetic tool that will provide a means of tracing the synaptic connections within any given neural circuit. This work will therefore provide a new basis for large-scale characterization of neural circuits in genetic model organisms, thereby filling an important technological gap. Moreover, as arboviruses closely related to Sindbis represent a common cause of viral encephalitis in the United States, a deeper understanding of the molecular mechanisms that influence viral spread in the brain will identify new therapeutic targets. Specific Aim 1. What are the genes and pathways restricting viral transcription, and particle assembly? Drosophila genetics and, more recently, unbiased RNAi screens on cultured cells, have revealed genes and pathways important for the antiviral response. However, it remains unclear how these factors affect viral replication and particle formation in vivo. For instance, previous experiments provide little information about which tissues are affected, nor what part of the viral replication/budding cycle is perturbed. We propose that transgenic flies carrying inducible Sindbis replicons are the perfect tool for visualizing viral transcription, replication, and particle assembly in vivo, as well as for identifying new host factors and pathways required for these processes. In order to achieve these goals we will proceed as follows: a. Using a novel in vivo infection sensor, we will characterize the spatio-temporal pattern of virus replication and particle dissemination in flies carrying mutations in different antiviral pathways. b. Using luciferase- expressing replicons we will quantify in vivo viral transcription in different tissues, upon systematic inactivation of host factors, using a public UAS-RNAi library. c. We will identify host factors required for particle assembly in a similar screen, by measuring the efficiency of virus particle production. Specific Aim 2. Which modifications increase neurotropism and synaptic transfer of Sindbis particles? Very few viruses have been successfully used as trans-synaptic tracing tools for neuronal network re- construction. Precision of existing tracers like Rabies is limited by the fact that they have to be injected into the tissue of interest, and purified, pseudotyped have to be constantly produced, and purified. We have shown that the RNA virus Sindbis can be "launched" cell-type specifically, through inducible expression of its genomic RNA and consecutive self-assembly in vivo. Moreover, Sindbis replicates readily in neurons, and has previously been shown to pass through synapses. We hypothesize that launched Sindbis particles of optimized neurotropism and with synaptically targeted glycoproteins can be developed into an efficient, molecular-genetic circuit tracing tool. a. To identify the Sindbis sequences with elevated neurotropism, we will serially passage Sindbis virus in Drosophila neuronal cell culture. b. By introducing neurotropic glycoprotein variants, we will increase viral spread in the brain. c. To target virus particle budding to the synapse, we will fuse 'synaptic targeting sequences' to the viral glycoprotein and will test these transgenes in anatomically well-described model circuits. d. By optimizing viral replication, particle assembly, neurotropism, and synaptic localization, we will develop a molecular-genetic toolkit for trans-neuronal tracing in Drosophila. !